FIRST Coordination and Evaluation Center to promote inclusive excellence

National Initiative on Gender, Culture and Leadership in Medicine: C-Change
Project Summary/Abstract
The FIRST CEC is requesting support for research/analyses that are within the original scope of
an active NIH research grant U24MD017138-03 in order to expand the FIRST Program awardee
sites’ ability to use C-Change Faculty Survey (CFS) data both formatively and for summative
evaluation of their sites, without compromising the identification of survey respondents. The
CEC will create datasets that the sites will use to evaluate institutional culture at their own
sites.
The CFS is a validated instrument measuring 17 dimensions of the existing institutional culture
that is often used to support the professional and personal development of faculty in academic
medical centers and the health sciences. The survey provides an assessment framework for
inclusive excellence and for research programs, program evaluation, and change activities. The
CFS assesses faculty perceptions of their institutional culture and professional experiences,
including: levels of vitality, trust, professionalism, feelings of being respected and belonging,
gender and diversity, inclusion, respect and equity, mentoring, extent of valuing diversity,
antisexism and antiracism skills, change agency for equity, and other constructs related to the
organizational culture for faculty.
Thus far, C-Change has collected survey data at the following sites:
Cohort 1
Cornell University November 2022
San Diego State University November 2022
Drexel University March 2023
Florida State University March 2023
University of Alabama at Birmingham/Tuskegee University Partnership March 2023
Icahn School of Medicine at Mount Sinai June 2023
Cohort 2
University of Maryland School of Medicine/Baltimore County Partnership May 2023
University of New Mexico May 2023
Northwestern University June 2023
University of South Carolina October 2023
University of California San Diego November 2023
Cohort 3
University of Texas at El Paso March 2024
[All other Cohort 3 sites are pending data collection in October 2024]
FIRST Program awardees are required to evaluate site-level institutional culture change as
described in RFA-RM-22-008.
All PIs and Data and Evaluation leads were surveyed to collect their feedback to an initial
proposal draft. This administrative supplement proposal is responsive to all feedback and
requests made by sites regarding their needs for CFS data.

Public health relevance
National Initiative on Gender, Culture and Leadership in Medicine: C-Change Project Narrative The FIRST CEC is requesting support for research/analyses that are within the original scope of an active NIH research grant U24MD017138-03. FIRST Program awardees are required to evaluate site-level institutional culture change as described in RFA-RM-22-008.